PlanB2CureHIV (the 'PlanB' consortium)

PROJECT SUMMARY
Antibodies capable of neutralizing the global diversity of HIV strains are difficult to elicit in humans. This is
because such antibodies require unusual features deriving from rare precursor B cells that must undergo
extensive affinity maturation. To date, only a small number of potent broadly neutralizing antibodies (bnAbs)
have been isolated after screening thousands of patients responding to unsuppressed infection. Passive
immunization with recombinant monoclonal HIV bnAbs however, can maintain suppression of viremia in
patients after anti-retroviral treatment (ART) interruption for as long as serum titers remain above threshold
effective serum concentrations. This suggests that establishing durable bnAb titers above these thresholds
could result in an HIV functional cure, defined as life-long suppression of viremia. Since HIV bnAbs cannot
be elicited through vaccination, gene therapies are being considered as an approach to deliver such long-
lasting bnAb titers in vivo. Of these, genome-edited B cells are a novel and promising approach that may
hold several key advantages. Primary B cell antigen receptors (BCRs) can be reprogrammed to express
novel specificities by inserting antibody transgene cassettes into the IgH-locus downstream of endogenous
heavy chain (HC) immunoglobulin (Ig) variable region exons. These modified cells can be expanded and
differentiated in vivo by vaccination into memory and long-lived plasma cells that can durably secrete the
new antibody specificity in wild type immunocompetent mice by independent research groups. The overall
purpose of the PlanB consortium is to accelerate the pre-clinical development of safe and effective IgH-
reprogrammed B cell-based therapies that would provide life-long bnAb titers capable of maintaining
suppression of the viral reservoir, allowing patients to discontinue ART therapy. Our aim is to develop and
compare two distinct options from which one could be selected for clinical development upon completion
of the program. The first is an ex vivo reprogrammed B cell product that can be autologously transferred
and vaccinated in patients. The second is an in vivo B cell targeting and IgH-reprogramming system that
will be used in conjunction with vaccination. In both cases, durable HIV broadly neutralizing antibody
memory responses must be elicited from the engineered cells.

Public health relevance
PROJECT NARRATIVE This program accelerates the pre-clinical development of safe and effective IgH-reprogrammed B cell therapies designed to provide life-long broadly neutralizing antibody (bnAb) titers through vaccination as an approach to an HIV functional cure. An ex vivo reprogrammed autologous B cell therapy program will be developed in parallel with one that aims to engineer B cells in vivo.